Finalizing and Testing an Online Therapist Training and Assistance Program to Facilitate Implementation of Comprehensive Behavioral Intervention for Tic Disorders (CBIT-Trainer)

Abstract (Project 2R44MH111450-03A1)
Tic disorders (TDs) are a class of neurodevelopmental disorders characterized by involuntary
motor and vocal tics1 that affect 1%-3% of the population2 and cause substantial distress,
interference and disability.3-9 Comprehensive Behavioral Intervention for Tics (CBIT) is an
empirically-validated collection of behavioral tic management techniques that is now
internationally recommended as a first-line intervention for patients with TD 10,15,16. Although CBIT
is effective and highly desired by patients,8,17-19 it is not widely available due to a lack of trained
providers.8,17-19 Within the current Phase II SBIR project, we successfully employed a stakeholder-
informed CTAP implementation framework21 and iterative development process to create an
interactive online program for training therapists to administer CBIT (CBIT-Trainer) and pilot
tested the program with a sample of CBIT-Naïve therapists. Results from the pilot test surpassed
our a priori criteria for initiation of the final stage of the project, which is to conduct a large-scale
test of CBIT-Trainer, examining both therapist and patient outcomes, using an effectiveness-
implementation hybrid approach23 to conduct a randomized controlled noninferiority trial
comparing CBIT-Trainer to the gold-standard in-person BTI training (BTI). The primary and
secondary aims of the clinical trial are to (1) compare CBIT-Trainer to the in-person BTI on
therapists’ ability to administer the core components of CBIT; (2) to compare patient response to
CBIT when treated by a therapist trained via the in-person BTI or CBIT-Trainer; and (3) to identify
therapist-level facilitators/barriers to adopting CBIT-Trainer and to implementing and sustaining
CBIT as a first-line intervention for TD patients after training.

Public health relevance
Rationale of the Proposed Administrative Supplement The proposed administrative supplement will enhance the parent award in two primary ways. First, it will provide the funds necessary to conduct additional BTI trainings in the remaining study period. Second, it will allow us to strategically recruit and enroll therapist-patient dyads from underrepresented and under-resourced practice areas. Specifically, in order to meet the recruitment aims of the clinical trial, we proposed to conduct all study-related trainings (BTIs) in densely populated urban areas (e.g., locations with Tourette Association of America designated Centers of Excellence) as a way to maximize the volume of potential participants. Based on the demographics of therapists who have expressed interest in the study thus far, we anticipate this strategy will result in an over-recruitment of therapist-patient dyads from large population centers and therapists with the time, institutional support, and resources to travel to, and attend, the in- person study trainings. This trend is consistent with recently updated internal data from the Tourette Association of America showing that most therapists who have been trained through the BTI are largely concentrated in large metro areas, with a relative dearth of CBIT-trained therapists in rural portions of the United States (e.g., New York, NY lists 59 trained therapists whereas ND, SD, MT, ID, NV, NE, KS, and NM have 0-2 trained therapists statewide). Although enrolling therapists and patients from underserved and underrepresented backgrounds/practice areas has always been part of our recruitment goal (and allowable within the study parameters), our current recruitment approach has provided us with initial data to suggest that we risk inadequate representation of therapist-patient dyads from underrepresented and under-resourced practice settings, likely due to logistical and budget constraints to travel to in-person BTIs. Among the 68 therapists who have been screened and deemed to qualify for the study thus far, 94% are from large metro areas with TAA Centers of Excellence or major medical centers with existing CBIT- trained therapists (within 50 miles) and only 6 (9%) are from the most underrepresented states per the TAAs referral finder database (i.e., states that currently have 5 or fewer CBIT-trained therapists statewide). Thus, the primary purpose of this supplement is to conduct targeted outreach and recruitment of therapist-patient dyads from underrepresented and under-resourced practice areas in order to ensure broad representation among participants, such as those residing in rural settings, lower-income urban areas, and providing/receiving care in community mental health clinics. Such settings have been shown to have unique challenges regarding the adoption and implementation of evidence-based mental health interventions,65,66 thus targeted recruitment of therapist-patient dyads from these settings could significantly increase the impact and commercialization of CBIT-Trainer and the generalizability of findings from our clinical trial. For example, the use of online platforms to deliver mental health interventions has accelerated considerably since 2020 and initial qualitative feedback collected from our expert advisory panel suggests that the addition of telehealth-specific training modules and resources within CBIT- Trainer might enhance adoption, especially among rural practitioners. CBIT-Trainer was intentionally built to allow for the rapid development and inclusion of such additions should relevant stakeholders deem them important for adoption, and the EPIS framework we are employing in the current project is ideally suited to identify such factors so long as the relevant stakeholders are identified, recruited, and enrolled in the study. With the current administrative supplement we propose to (a) engage in targeted recruitment and enrollment of therapist-patient dyads from under-resourced practice settings and under-served areas in order to enhance the generalizability of our RCT by (i) conducting additional therapist trainings in underrepresented areas and (ii) providing stipends to therapists from identified underrepresented settings/areas/groups to attend in-person BTI trainings in order to remove financial barriers to participating in the study; (b) utilize our established CTAP framework to examine implementation factors that facilitate/inhibit adoption of CBIT-Trainer and sustained use of CBIT within such settings; and (c) utilize the same iterative feedback process employed during the development of CBIT-Trainer to make program modifications/enhancements to increase adoption and implementation of CBIT among therapists practicing in under-resourced and under- served settings.